Cancer Research Training and Education Coordination Core

CANCER RESEARCH TRAINING AND EDUCATION COORDINATION CORE (CRTECC)
Overview of the University of New Mexico (UNM) and the University of New Mexico Comprehensive
Cancer Center (UNMCCC) Environment and Resources for Success
The University of New Mexico is both a Minority Serving Institution and a Research Intensive University in the
Carnegie Classification. In the 2019 College Factual Rankings, UNM ranked in the top 15% of 2,238 colleges
and universities analyzed for diversity. The ranking is based on diversity of race, age gender, and geographic
origin. Additionally, the diverse student, staff, and faculty constituencies are institutionally supported through a
Vice Chancellor for Diversity (UNM HSC) and a Vice President for Equity and Inclusion (UNM main) who
collectively oversee services and offices that promote and embrace equity and inclusion as detailed below.
Scholars and Research Mentors have ready access to a wide array of Institutional Resources across the Health
Sciences Center and Main Campuses of the University of New Mexico, as detailed below. The Resources include
numerous centers of research excellence, research instrumentation, professional development support, and
offices in support of education and diversity. On the Health Sciences Center Campus, UNMCCC scholars are
distributed among the School of Medicine, the College of Pharmacy, the College of Nursing, and the College of
Population Health each with unique resources, certificate and degree offerings. On the main campus scholars
are distributed between the College of Arts and Sciences and the School of Engineering. Current, past, and
prospective research mentors represent over 20 participating departments and divisions.
It is within this context that the University of New Mexico Comprehensive Cancer Center (UNMCCC) has
assembled its Cancer Research Training and Education Coordination Core (CRTECC) Office, staff, and
leadership team as further detailed in the Research Strategy section. CRTECC leadership interfaces with
UNMCCC Research Programs and Share Resources, Translational Science Initiative (TSI), Geographic
Management of Cancer Health Disparities Program (GMaP), Community Outreach and Engagement (COE)
Core, and the Cancer Research Administration, (detailed in individual sections) in support of the training
spectrum covered by the UNMCCC. The long-term goal of the Cancer Research Training and Education
Coordination Core is to motivate diverse trainees, through culturally relevant training, to assume careers in
cancer-focused population sciences, basic and translational science research. More specifically, the training
programs at the UNMCCC match HS through junior faculty with outstanding research or clinical mentors. Mentors
have broad research interests and are engaged in basic cancer research to clinical translation. Moreover, the
intellectual environment is rich with extramurally funded investigators who are pursing cancer research
encompassing community participatory research to clinical trials. The UNMCCC supports internationally
recognized speakers, workshops, seminars and retreats, which offer skill- and team-building opportunities.
Activities and career tracking are supported by a central office, and evaluated by Senior Leadership, an external
evaluator, and an internal Advisory Committee for Education (ACE). ACE members (listed on following page)
represent consortium partners, multiple departments, schools and colleges on UNM HSC and main campuses,
and bring perspectives on education leadership and programming for HS to junior faculty levels, best practices
for developing a diverse workforce, and multidisciplinary research. The Behavioral Measurement and Population
Science (BMPS) core and career tracking provide assessment and outcomes data used for continual program
improvement. Collectively, the UNMCCC training programs contribute to shaping the face of a diverse faculty
and student body educated in cancer research and clinical translation. UNMCCC trainees will productively
contribute to tackling the significant education and health needs of underserved communities locally and
nationally. The training and mentoring infrastructure developed by the UNMCCC, together with the other
resources described below, collectively provide a scientific environment, professional and career development
opportunities that are strongly supportive of the Cancer Research Training and Education Core stakeholders.